HOST AND TUMOR CELL IPLA2 IN OVARIAN CANC

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Host-tumor cell interaction has been recognized as a critical factor for tumor development. We have shown that calcium-independent phospholipase A2 (iPLA2) is important for regulating extracellular lysophosphatidic acid (LPA) levels in human epithelial ovarian cancer (EOC) cells.